A novel algorithm to compute adherence from electronic adherence monitoring devices

PROJECT SUMMARY/ABSTRACT
Medication adherence is a current scientific priority of the National Cancer Institute and a top priority in clinical
trials. Electronic adherence monitoring devices (EAMDs) are pill bottles or boxes that contain a computer chip
that records the dates and times of each bottle/box opening (or “actuation”). Due to their accuracy and ability to
capture day-to-day medication-taking behavior, EAMDs are increasingly cited (i.e., by the FDA) as the
preferred measure of daily anticancer medication adherence in research. Unfortunately, researchers currently
lack the tools they need to accurately and efficiently convert raw EAMD actuations into adherence data and
current methods of completing this task are unstandardized, error-prone, and burdensome. The purpose of this
R21 is to develop a novel algorithm to convert EAMD actuations into adherence data. To maximize potential
uptake and usability, we will engage a multidisciplinary adherence science focus group to inform the design of
the algorithm and associated user interface (Aim 1). We will then evaluate the accuracy of the algorithm in
classifying daily adherence data (Aim 2) and obtain quality of use feedback (Aim 3) to inform final refinements
prior to large-scale testing.

Public health relevance
PROJECT NARRATIVE Rigorous adherence measurement is critical for advancing adherence science and clinical trials research. The proposed research responds directly to the National Cancer Institute’s call for data processing algorithms to address priority needs, like adherence, in cancer research and will result in a novel algorithm and user interface that can convert electronic adherence monitoring device actuations into adherence data. These tools will have the potential to transform the pace, rigor, and efficiency of research using electronic adherence monitoring devices to assess adherence.